Extracellular vesicle transport of brain-derived proteins to the blood in Alzheimer disease

Summary
Growing evidence suggests that extracellular vesicles (EVs), membrane vesicles that can be
secreted by most cell types to mediate intercellular communication, play important roles in the
initiation and or progression of Alzheimer disease (AD). Specifically, it has been demonstrated that
cell-to-cell transfer of amyloid beta (Aβ), tau, and other proteins critically involved in AD
pathogenesis, as well as the prion-like propagation of AD pathology within the central nervous
system (CNS) is mediated at least in part via EVs. Additionally, EVs carrying unique, disease-
specific, and functionally important cargo are detectable in vivo in blood, cerebrospinal fluid (CSF)
and other body fluids. More recently, we and others have demonstrated not only that EVs may
cross the blood-brain barrier (BBB), though the transportation mechanism remains unclear, but
also that blood-based but CNS-specific EV molecules can be a valuable source of biomarkers for
neurodegenerative diseases, including AD. In this study, we will first use our advanced proteomics
techniques to screen for EV surface markers specific to AD-related neuronal subpopulations or brain
regions to identify more CNS- and AD- specific EV markers, and in parallel adapt our nanoparticle
sorting and single-molecule quantification technologies to enable high-purity isolation of CNS-derived
EVs in plasma and high-precision quantification of proteins in such EVs to address several major
challenges in the current field. Using the currently known (e.g., L1CAM) and more CNS- and AD-
specific, CNS-derived EV surface markers, as well as the existing and further developed EV isolation
and quantification technologies, we will then compare AD-related biomarkers in L1CAM-containing
EVs or those from AD-related neuronal subpopulations in blood plasma from human patients,
focusing on the performance of classic AD proteins and known EV candidates, specifically, Aβ, tau,
α-synuclein, and their various isoforms; additional novel targets may be studied when necessary. For
the verified AD-related EV proteins, we will further examine their longitudinal changes in animal
models and explore the mechanisms by which they are transported from the brain to blood (e.g.,
crossing BBB) in cellular and animal models and potential ways to alter them as novel future AD
treatment targets. The proposed experiments will likely establish the foundation leading to an
inexpensive and widely available test to aid in AD diagnosis and/or disease tracking. Additionally, the
proposed set of studies is an important initial step toward elucidating a novel potential clearance
pathway for potential toxic CNS protein species and ultimately it may provide critical opportunities for
therapeutically addressing the pathology associated with neurodegeneration in AD.

Public health relevance
Project Narrative Alzheimer disease (AD) affects millions of Americans and many more worldwide and is a significant source of disability and a major burden to society. This study aims to investigate the transportation or clearance of potential toxic proteins from the brain to blood via small membrane vesicles and the potential usage of such proteins in blood plasma as AD biomarkers. The study will likely establish the foundation leading to an inexpensive and clinically routine test that improves AD diagnosis accuracy and/or enhances disease progression monitoring, and ultimately may provide critical opportunities for therapeutically addressing the pathology associated with neurodegeneration in AD.